LIGHT THERAPY OF CHILDHOOD AND ADOLESCENT DEPRESSION

Test the hypothesis that light therapy reduces symptoms of depression in childhood and adolescence and that the response to light therapy is associated with abnormal suppression of melatonin to light in probands and their first degree relatives.